Mimicking kidney flow shear to investigate systemic amyloidosis

Project Summary
Systemic amyloidosis (SA) is a group of serious disorders caused by misfolding of ~20 circulating proteins
and their subsequent fibrillization and deposition in various organs. The most common forms of SA involve
misfolding of immunoglobin light chain (LC), transthyretin (TTR), and leukocyte cell-derived chemotaxin-2
(LECT2), and aggregation of these proteins causes kidney and heart dysfunction. Some of the factors that
contribute to the misfolding of these proteins are known or suspected, such as destabilizing mutations and loss
of bound cofactors, but the underlying molecular mechanisms of SA remain undefined.
This proposal pursues the hypothesis that laminar flow shear in the blood, in combination with known
conditions that destabilize the affected proteins, is a major driver of protein misfolding in the circulatory system
and development of SA. The principal innovation is the introduction of microfluidic devices that recapitulate
the dimensions and highly branched structures of the human kidney vasculature, through which ~1 L of one’s
blood passes each minute. These structures create shear stress conditions that are extensive and unique in the
body.
These devices will be used to subject LC, TTR, and LECT2 to the form of physio-mechanical stress that
they experience in circulation, to induce specific local unfolding events that bring about their aggregation into
amyloid fibrils. The project employs cryo-EM, fluorescence, and biophysical experiments to characterize the
structures and properties of misfolded forms generated by the microfluidic devices, including liquid-liquid
phase separated condensates and mature amyloid fibrils. Amyloid structures will be compared to those
previously obtained from diseased human kidney and heart to test the hypothesis that flow shear reproduces the
ex vivo structures.
Finally, small binding domains that recognize misfolded forms of LC and TTR will be generated, and
fluorescent and luminescent biosensors will be created by plugging these domains into the PI’s existing modular
sensor designs. Biosensors will be tested using patient serum and urine. This aim addresses the critical need for
an early diagnostic test that can be performed at point-of-care, to detect SA prior to the onset of organ damage.

Public health relevance
Project Narrative This project seeks to uncover the molecular mechanisms that are responsible for systemic amyloidoses, a group of serious disorders caused by misfolding of proteins in the bloodstream, and to develop novel biomarkers and biosensors for their detection. The hypothesis is that flow shear in the blood is a major driver of protein misfolding in the circulatory system and development of systemic amyloidosis. The principal innovation is the introduction of microfluidic devices that recapitulate the vasculature of the human kidney. These devices are employed to generate relevant species for structural and mechanistic investigation, and disease-mimicking biomarkers that will be used to develop the first biosensors for early detection of systemic amyloidoses.